National Consortium on Alcohol and Neurodevelopment in Adolescence: OHSU

PROJECT SUMMARY
Initiating excessive alcohol drinking during adolescence is known to disturb typical neurodevelopmental patterns,
increase the risk of developing alcohol use disorder (AUD), and accelerate involutional processes in adulthood.
In response to RFA-AA-21-007, this application proposes a Research Project Site of the National Consortium
on Alcohol and Neurodevelopment in Adolescence - Adulthood (NCANDA-A) to follow for the next 5 years a
diverse community sample of mostly no-to-low male and female drinkers at baseline that NCANDA recruited
when age 12-21 years and has tracked over the last 8 years (N=831; 93% retention rate) across 5 sites.
Monitoring has involved annually-acquired multimodal neuroimaging (MRI, DTI, resting state fMRI, task fMRI),
cognitive, clinical, behavioral, and biological data, collected in person or remotely by computer and our mobile
app. These measures will now be complemented with new advanced neuroimaging and sleep and physical
activity tracking. This cohort sequential design uniquely positions NCANDA-A to quantify transient or enduring
alcohol-related disturbances in specific adolescent and early adult neural system growth trajectories and
functional concomitants.
NCANDA-A proposes four consortium-wide specific aims and two specialty project aims. In Aim 1, NCANDA-A
will investigate the impact of excessive alcohol drinking during adolescence and emerging adulthood on
subsequent developmental trajectories of cognitive performance, brain structure and function, and
psychopathology. Aim 2 analyses will identify neurodevelopment patterns describing the extent to which
alcohol's effects on brain structure and function resolve or persist during desistance after binge drinking. Aim 3
will deploy data-driven analysis to identify adolescent biological, environmental, and behavioral factors (e.g., age
of drinking onset) that forecast excessive drinking in individuals during early adulthood. In Aim 4, NCANDA-A
will quantify the impact of the COVID pandemic on life stress and social, emotional, and economic wellbeing and
their relations with alcohol use patterns. In Aim 5, the SRI and Pittsburgh sites will identify interactions among
patterns of alcohol use, sleep, and cardiac function. In Aim 6, the UCSD, Duke and OHSU sites will determine
the extent to which short-term (i.e., 4 weeks) alcohol use discontinuation results in acute improvement in
cognition, affect, sleep and resting heart rate, and reversal of the adverse structural and functional brain effects
of frequent binge alcohol use. For each aim, sex differences in development, alcohol use patterns and history,
impact of alcohol use on the brain, and sex-differentiating psychosocial factors will be tested.
With the longitudinal data collected into early adulthood during this renewal, NCANDA-A will provide novel
information to the public on the enduring and transient effects of adolescent drinking on adult functioning by
discovering elements and mechanisms linking these dynamic processes and identifying modifiable risk factors.

Public health relevance
PROJECT NARRATIVE Heavy alcohol drinking during adolescence is known to disturb brain development and functioning and increase risk of drinking problems in adulthood, but the extent of the lingering effects of youthful drinking on adult functioning remains unclear. The goal of NCANDA-A (Adulthood) is to determine how adolescent alcohol-related disruption of normal brain growth patterns of structure, related brain function, and psychiatric health affects brain functioning in emerging adulthood. Determining which affected processes remain impaired and which escape alcohol's untoward effects will specify how a youthful-drinking history influences quality of life in adulthood, information obtained only from longitudinal study as proposed by NCANDA-A.